Toward the Precision Diagnosis and Prevention of Acquired and Congenital Long QT Arrhythmias

PROJECT SUMMARY
Torsades de Pointes (TdP) and subsequent sudden cardiac death (SCD) is a severe life-threatening
arrhythmia that occurs in conditions that prolong the QT interval of the electrocardiogram (ECG). These
conditions include both congenital LQT which can be caused by genetic mutations in various cardiac ion
channels, as well as acquired LQT which is most commonly drug-induced, particularly through hERG
potassium channel blockade. The prevention of life-threatening TdP in drug-induced acquired LQT is of
particular importance as many new drug candidates fail to make it to market due to the FDA’s strict
requirements for a “thorough QT study,” rejecting drug candidates that prolong the QT interval significantly.
Thus, the development of both new precision diagnostics for predicting individual patient risk of acquired LQT
as well as new targeted therapeutics for preventing TdP in LQT patients are greatly needed. Given the
importance of QT prolongation on the FDA drug approval process, these advances would have broad
implications not only on congenital LQT patients, but on the entire drug development industry. The goal of this
proposal is to address these areas of need using artificial intelligence computational approaches and modern
gene editing techniques.
To this end, the applicant will develop a deep learning artificial intelligence ECG model to predict patient-
specific risk of drug-induced LQT during the loading of Class III anti-arrhythmic drugs such as sotalol and
dofetilide. These drugs are used to prevent arrhythmias but paradoxically also can increase the risk of sudden
cardiac death if a patient experiences QT prolongation. Therefore, patients must be hospitalized for serial QT
interval monitoring during initiation. A deep learning model that can predict in advance from the baseline ECG
which individual patients will develop LQT would enable us to precisely select only patients with a high
confidence of success to attempt a costly and inconvenient inpatient drug load. The applicant will also address
the need for new targeted therapies to prevent sudden cardiac death in both acquired and congenital LQT.
Prior work has implicated the L-type calcium channel window current in the mechanism of TdP arrhythmia
initiation. The applicant will investigate these predicted arrhythmia suppression effects in patient-derived
congenital LQT induced pluripotent stem cells (iPSC) using CRISPR gene editing to reduce the window
current. Improved understanding of this mechanism will be important in the pursuit of a universal therapy to
prevent arrhythmia in all LQT conditions. The training in this fellowship will be instrumental in the applicant’s
career development as a physician-scientist in electrophysiology.

Public health relevance
PROJECT NARRATIVE Sudden cardiac death is when someone dies without warning from a problem with their heart, most commonly due to a heart rhythm disorder. A condition called Long QT Syndrome, which can be caused by certain drugs or genetics, can increase the risk of sudden cardiac death. This proposal will combine artificial intelligence computational analysis of electrocardiograms with gene editing of induced pluripotent stem cells derived cardiomyocytes in order to improve the prediction and prevention of arrhythmias arising from both acquired and congenital Long QT Syndromes.